STRUCTURAL &FUNCTIONAL EFFECTS OF LIMB IMMOBILIZATION

The proposed investigation will examine structural and functional changes in immobilized limbs with particular emphasis upon the possible neurogenic factors influencing the manifestations of disuse. The research plan is to assess a number of criterion measures in noninjured limbs in order to obtain baseline data and then to evaluate several techniques of preventing the detrimental effects of limb immobilization. The criterion measures include: 1. limb volume, 2. maximal voluntary isometric strength, 3. forcetime characteristics, 4. strengthduration curve, 5. muscle endurance, 6. electromyographic parameters. Three techniques of preventing muscle atrophy will be evaluated. The first two, isometric exercise and transcutaneous electrical stimulation, are currently being used in some rehabilitation facilities. The third is a new method of functional electrical stimulation which has been shown to be successful for the restoration of movement in paralyzed limbs. No study to date has included structural and functional criterion measures to assess adequately the effects of limb immobilization. In fact, the vast majority of studies have concentrated on only one or two measures, such as limb circumference and strength. Not only does this investigation include a more complete set of criterion measures, but the techniques to be employed are more sophisticated and innovative. For example, the limb volumes and electromyographic patterns are fractionated into more meaningful components to allow interpretations of the exact manifestations of the disuse syndrome. Of the possible techniques to prevent muscle atrophy it is hypothesized that a more recent technique of functional electrical stimulation will surpass all methods currently employed to deter the detrimental effects of limb immobilization.